COMBINATION THERAPY OF PNEUMOCYSTIS CARINNI PNEUMONIA IN AIDS PATIENTS--ACTG 108

A Phase III comparative trial of Dapsone/Trimethoprim and Clindamycin/Primaquine versus Trimethoprim/Sulfamethoxazole in the treatment of mild-to-moderate PCP in patients with AIDS.